FY23 FACILITIES TO F

This project will repurpose exiting freezer B1403 at the ATRF to house a new crypo microscope. Walls will be constructed within B1403 creating an L-shaped freezer room and a separate space for microscopes.